Orion: A novel platform for rapid multiplexed tissue imaging

Abstract:
We propose to acquire an Orion HT multiplex fluorescent imaging system (Rarecyte inc.) to
support research at Brigham and Women’s Hospital (BWH) and neighboring institutions.
Immunofluorescence (IF) is a standard tool for microscopy research and is used routinely to
identify cell types and study their organization and function in tissues. However, the overlapping
emission spectra of common fluorophores means that standard IF is limited to a few colors,
which is a major limitation for studying cell interactions in complex tissues and disease states.
Many cell types can only be identified using combinations of several markers, and to understand
their interactions it is often necessary to visualize multiple markers simultaneously. Thus,
multiplex immunolabeling methods are essential. One approach is to perform multiple labeling
cycles, and various methods have been developed to achieve this. However, these cyclical
methods are slow and labor-intensive, and specimens can become degraded after multiple
cycles. The Orion instrument was developed to solve these problems, and to achieve highly
multiplex imaging in a single scan. Antibodies are conjugated to a palette of up to 20
fluorophores, excitation is produced by seven high-power lasers, and fluorescence is measured
through a series of tunable narrow bandpass filters. Following staining, multiple fluorescence
images are captured automatically, and individual labels are computationally separated using
the company’s SpectralEdge algorithm. The instrument can scan an entire slide at subcellular
resolution, which is especially important when studying large complex structures such as brain
or tumors, whose spatial heterogeneity is not adequately captured by smaller fields of view. The
Orion can also capture a H&E image on the same section, meaning that multiplex molecular
data can be correlated with existing H&E datasets from clinical pathology. The reliability of the
color separation has been extensively validated, and this novel technology holds great promise
for a wide range of applications. The PI, Sandro Santagata, has previously collaborated with
Rarecyte to develop the Orion technology, with support from a NIH SIBR grant. He also
collaborates closely with Peter Sorger at Harvard Medical school, a current advisor to Rarecyte.
Our users will benefit greatly from their expertise and connections to the company, and from a
growing list of validated antibodies and computational tools that have been developed to
support the Orion platform. The requested instrument will be installed in a shared core facility at
BWH, where it will support a large community of NIH-funded researchers studying cancer,
autoimmunity, inflammation, neurodegeneration and many other disorders.

Public health relevance
Project Narrative: The human body contains a great variety of tissues and cell types, which researchers must study under the microscope in order to understand their functions in health and disease. The requested Orion HT instrument features powerful optical technology that allows it to image up to 20 different color markers in a single automated scan, which will greatly expand our ability to identify multiple cell types within tissues and to visualize their interactions. The instrument will be installed in a core facility at Brigham and Women’s Hospital, where it will support a large community of NIH-funded researchers studying cancer, autoimmunity, inflammation, neurodegeneration and many other disorders.